Understanding how senescent stromal cells contribute to mammary gland tumorigenesis

Project Summary/Abstract
Breast cancer is the most frequent malignancy in women and aging is one of the largest risk factors for the
development of breast cancer. The accumulation of oncogenic mutations within incipient tumor cells and age-
related changes in the stromal compartment may together impact tumor progression. One change that occurs in
the tumor microenvironment is the accumulation of p16INKA4 (p16) positive senescent cells which express various
cytokines, chemokines, and enzymes that all together recognized as senescence-associated secretory
phenotype (SASP) factors. While SASPs from different cell origins can exert different effects on tumorigenesis,
SASP factors secreted by senescent stromal cells can not only directly promote the proliferation of tumor cells,
but also create an immunosuppressive microenvironment that ultimately leads to more robust tumor growth. The
less ideal response to immunotherapy among breast cancer patients raises the possibilities that senescent
stromal cells could be one of the barriers protecting breast tumor cells from current immune checkpoint blockade
therapies and that the efficacy of immunotherapy can be boosted when combined with senescent cell elimination
strategies. Since immunosuppressive SASP factors are detectable in human breast cancer stroma, I hypothesize
that senescent stromal cells contribute to mammary gland tumorigenesis by modulating regulatory T cells (Tregs).
Preliminarily, I have shown that depletion of senescent stromal cells can lead to significantly delayed mammary
tumor onset in a transgenic mouse model. In addition, I have found that orthotopic mammary tumor
transplantation with senescent fibroblasts results in higher tumor burden and more Tregs infiltration. Finally, my
single cell RNA-sequencing (scRNA-seq) analysis on murine and human mammary tumor/breast cancer dataset
reveals that senescence signature is highly restricted to a specific cancer associated fibroblasts (CAFs)
subpopulation and this population expresses elevated levels of several Treg-inducing factors. I thus propose to
perform further scRNA-seq analysis to identify gene expression signatures of senescent CAFs across breast
cancer subtypes and understand these CAFs’ impact on tumor microenvironment. Furthermore, I will conduct in
depth tumor immunity analysis on both transgenic and orthotopic injection mouse models to discuss how tumor
immune environment is shaped by the senescent CAFs and whether depletion of senescent stromal cells, using
both genetic and pharmacological tools, can exert synergistic effect when combined with immune checkpoint
blockade therapies. These aims will not only provide a comprehensive picture of the relationship between
senescent stroma and breast cancer development, but also help me pursue my interests in immunology and
translational medicine. The training received through this proposal will also strengthen my research skills in
immunology and cancer biology. These skills will allow me to push forward my career goals of facilitating bench-
to-bedside research in cancer therapy.

Public health relevance
Project Narrative Recent studies have revealed that senescent stromal cells can secret factors to modulate tumor immune surveillance and thus promote tumor progression. Given that such factors have been identified in human breast cancer tissues across molecular subtypes and immunotherapy response amongst breast cancer patient is far from ideal, it is critical to understand how senescent stromal cells contribute to mammary gland tumorigenesis. The aims proposed here will not only broaden our understanding in how senescent stroma shapes tumor microenvironment but also help to identify potential strategies to improve response to immunotherapy by targeting cellular senescence.